Phosphatases in lupus

Systemic lupus erythematosus (SLE) presents profound T cell dysfunction and cytokine production.
Decreased production of interleukin (IL)-2 and increased production of IL-17 contribute to compromised
immune system homeostasis and the development of organ inflammation. Protein phosphatase 2A (PP2A), a
trimolecular enzyme consisting of scaffolding, catalytic (c) and regulatory subunits, has been shown to control
molecules involved in immune cell signaling and gene transcription resulting in suppression of the production
of IL-2, enhancement of the production IL-17 and the generation of Treg and Th17 cells. PP2A has been
recognized to contribute first to human SLE and later to murine lupus immunopathology. New preliminary
experiments have revealed that PP2A controls in a direct manner the expression and function of distinct
enzymes involved in glycolysis and the pentose phosphate pathway. The consorted effect of PP2A on these
metabolic enzymes leads to compromised Treg function and poor control of the inflammatory response. This
proposal will test the hypothesis PP2A controls the development and function of Treg cells by acting directly on
intracellular enzymes involved in cell metabolism. In three sets of experiments, we will determine how PP2A
controls the function of enzymes involved in the glycolysis and pentose phosphate pathway pathways; will
establish that a PPP metabolite, gluconolactone can control inflammation and systemic autoimmunity in mice;
and will establish that enzymes of the PPP are aberrantly expressed in people with SLE. The proposed work
advances concepts whereby T cell function is regulated in an exact manner through the control of intracellular
metabolic enzymes. The study will use mice with conditional deficiency of PP2A or PPP enzymes in Treg cells
and normal or lupus-prone mice engineered to expressCas9-Gfp only in Treg cells. Advanced cell-targeted
delivery of small drugs and gRNA will be used in Cas9 mice. The significance of the proposed work is with the
identification of novel targets to control immune response homeostasis and is further affirmed with the
discovery of metabolites which, when used either in vitro or in vivo, may control organ inflammation and
autoimmunity.

Public health relevance
Systemic lupus erythematosus afflicts more than a million Americans with significant morbidity and mortality especially among people of Black and Asian background. The available treatment approaches and tools to record response to treatment are limited. The project proposes to introduce novel molecules which are involved in cell metabolism in the treatment of patients.